Cytokine Profiles In Asthma And Allergic Diseases

Asthma is an inflammatory disease of the airways. After allergen exposure, IgE bearing cells, such as mast cells and basophils, are first activated. Later, T lymphocytes enter the airways, are activated by allergen and play a key role in regulating this inflammatory response through the elaboration of cytokines such as IL-4, IL-5 and IFN-gamma. This project seeks to examine the cytokine and mediator profiles of mast cell, basophil and T cell subpopulations that may be involved in the generation of inflammation in asthmatic airways. We have developed sensitive intracellular cytokine assays to measure allergen specific T cell cytokine responses almost directly ex vivo. Using these methods, we have shown that allergen specific T cells are predominantly of the classic Th2 phenotype and that on the single cell level IL-4, IL-5 and IL-13 are highly co-expressed. Interestingly, IL-2, which is often considered a Th1 cytokine was also highly coexpressed. Allergen specific T cell expressed high levels of the CCR4 and CRTH2 chemoattractant receptors. These results provide a detailed view of the T cell response to allergens with a fidelity heretofore not possible.